Neuronal and behavioral responses to spinal cord injury

Project Summary/Abstract
The toll of spinal cord injury on people and society is substantial, and particularly so when hand function
is impaired and independence lost. We use well defined spinal cord injury (SCI) models in nonhuman
primates and rodents to delineate the responses of major ascending and descending tracts, that
reorganize post-injury and that mediate the recovery of hand function. Our past work shows that spinal
injuries that remove sensory input from the opposing digits, can cause an initial deficit in hand function,
from which monkeys recover over weeks and months post-lesion. This recovery occurs despite the
permanent loss of most of the original sensory innervation to the hand. We have shown that spared
primary motor (M1) and somatosensory (S1) cortical subdivisions of the corticospinal tract (CST) sprout
extensively and bilaterally beyond their normal terminal territory within the cord following a
deafferentation injury, but only when the injury involves the central nervous system. Similar responses
can be demonstrated in rats which indicates the response is robust and conserved across mammalian
species. In this grant, we will address some major gaps that remain in our understanding of the
recovery process. We will do this by determining what happens at the neuronal circuit level, at the
periphery, and following a more clinically relevant lesion involving both sensory and motor components.
Our main focus is on monkeys, where our findings are directly translational, and on sub-chronic and
chronic time points following injury. These are times when patients are more accessible to intervention,
and the chronic time point in particular is poorly understood. Our specific aims in summary are as
follows: 1. What happens to the central neuronal circuitry following a deafferentation injury? Here we
will target the major inputs to the spinal cord (from the hand and cortex) and their connections, to
assess how they reorganize to mediate the recovery of hand function. 2. How do peripheral nerves and
receptors compensate for lost innervation to support significant recovery of sensation in the hand? 3.
How does the addition of a small motor component to our lesion model, alter the recovery process and
underlying connections? The lesion models to be used are particularly well defined, and involve
peripheral and central, as well as sensory and motor components, which makes them clinically relevant.
We use behavioral, electrophysiological, and a range of neuroanatomical techniques (including high
resolution confocal microscopy), as well as powerful multifactorial statistical modeling to assess
changes. Our findings will improve our understanding of the changes that occur in clinical injuries, and
better enable the future development of effective treatments for people with spinal cord injury. Findings
will be set in a broader context of behavioral recovery and system wide neuronal responses.

Public health relevance
Narrative Spinal injury that involves the cervical cord can severely impair hand function in humans and result in loss of independence. We use clinically relevant models of spinal injury in the monkey and rat to study central neural mechanisms responsible for the recovery of hand function. Our findings will provide novel insight into the neuronal reorganization that takes place post-injury, which is needed if patients with spinal injuries are to be treated more effectively.